Signaling mechanisms underlying neural crest cell fate decisions

The neural crest contributes a wide variety of cell types to the human face, giving rise to teeth, melanocytes,
the craniofacial skeleton, and the peripheral nervous system. The diversification strategies used by the neural
crest are still elusive, but seem to be highly sensitive to genetic perturbations because heritable diseases
frequently disrupt neural crest development, which can impact craniofacial growth. Thus, clarifying how cell
interactions bias neural crest cell fates could reveal mechanisms of disease progression, many of which
remain obscure. To perform a systematic characterization of neural crest lineages and their developmental
regulation by cell signaling, we have built upon our recent breakthroughs in single-cell transcriptomic analysis
to include viral gene delivery for functional interrogation. Using barcode-based clonal lineage tracing and high-
throughput genetic perturbations in vivo via ultrasound-guided injections of lentivirus into the forming cranial
neural crest region, we will map how cell lineages interact and diversify to build the face. Based on our
preliminary data, we hypothesize that neural crest cells utilize collective multipotency, and
communicate via signaling interactions in the dorsal neural tube that balances molecular biasing of
early neural crest cells towards fates in correct proportions. We will test this hypothesis by functional
experiments targeting receptors and ligands in neural crest subpopulations, with special emphasis on genes
that when mutated, can result in pathology. By assembling a global collaboration of experts in advanced
imaging techniques, single-cell transcriptomics, and mammalian genetics, we will determine the disease
mechanisms underlying failures in facial development, and in doing so, contribute valuable datasets for the
craniofacial and neural crest biology communities. Successful completion of our research plan will illuminate
potential avenues to manipulate the behavior of stem cells at the population-wide scale, and reveal how cell
fate choices could be manipulated in specific locations in vivo to generate skeletal shape and form. This three-
year postdoctoral training plan is an excellent opportunity for the candidate to train at a world-renowned
medical research environment, while gaining a unique combination of skills, background and network that will
make a clear path towards scientific independence.

Public health relevance
Neural crest cells (NCC) contribute many cell types that make up the human face, but the signaling interactions and strategies used by NCC and other stem cell populations to drive cell fate decisions are unknown. By employing a new approach for viral gene delivery, transcriptomics, and bioinformatics, we will reconstruct the tree of NCC fate decisions during craniofacial development, and model the cellular mechanisms of craniofacial pathologies. The project aims to help create new cell-based therapies and improve genetic consultancy, by improving our understanding of how molecular signals coordinate stem cell behaviors during development.